Expanding the Gateway infrastructure: Supporting causal research on the role of childhood education for determining AD/ADRD-related outcomes

Summary
Education is considered a key determinant of cognitive function and a potential driver of
disparities in AD/ADRD risk and resilience, and education policies lead to widely different
educational trajectories across cohorts and countries, which likely contribute to disparities in
late-life cognitive outcomes in older age. Collecting, harmonizing, and sharing data on education
policies can therefore support rigorous research to understand how education impacts
cognition. However, these policies are complex to understand and time consuming to collect,
and as a result, research in this area has been hampered by the absence of a rigorous and
systematic data collection infrastructure on historical education policies.
The Gateway to Global Aging Data (Gateway) is an NIA-supported data sharing and discovery
project that facilitates cross-country, longitudinal research on aging, health, and retirement using
data from the Health and Retirement Study and its International Network of Studies (HRS-INS)
and the Harmonized Cognitive Assessment Protocol (HCAP) international network of studies. A
central component of the Gateway’s work is the Policy Explorer, a digital tool that compares
historical policy changes over time. In 2022 the Policy Explorer’s efforts expanded to include the
collection and documentation of education policies. These efforts collected compulsory
schooling reforms since 1900 in 22 countries and 31 U.S. states.
To support research into the impact of education on AD/ADRD, the Gateway proposes to
expand collection of historical education policies to include early childhood, primary, and
secondary education policies that affect individuals globally and are pivotal to early and mid-life
choices and late-life outcomes. We will collect novel data and document changes in primary and
secondary education policies, focusing on reforms likely to influence disparities in access,
quality, and type of education, including access to free schooling; sex and race/ethnicity-based
differences in education delivery; and policies affecting public education financing and
expenditures. In addition, we will gather novel data and document historical early childhood
education and care policies. Using this documentation, we will develop harmonized education
variables to support the replicable use of these policies in research. To accelerate AD/ADRD
research, we will make our documentation and associated measures freely available through
the Gateway and HRS-INS and HCAP networks, and host outreach activities aimed at spurring
research and encouraging cross-national collaborations.

Public health relevance
Project Narrative Education, a key determinant of cognitive function, is shaped by historical policies that led to widely different educational experiences across countries and cohorts. However, collecting education policies is complex and time consuming, which requires systematic policy data collection efforts to support and accelerate research into the impact of education on AD/ADRD risk, resilience, and disparities. The Gateway to Global Aging Data will expand its collection and dissemination of free, publicly available documentation on the evolution of pivotal policies affecting early childhood, primary, and secondary education across countries in the international network of health and retirement studies and across US states and create harmonized variables to support their replicable use in research.